Decoding Bariatric Surgery Outcomes through Activity and Transcriptional Analysis of Melanocortin Neurons

PROJECT SUMMARY
Bariatric surgeries, such as Vertical Sleeve Gastrectomy (VSG) and Roux-en-Y Gastric Bypass (RYGB), are
highly effective interventions for obesity and related metabolic disorders. While they lead to weight loss and
improved glucose metabolism, the neural mechanisms underlying these effects are not fully understood. These
data suggest disparate and spatially distinct activity profiles of arcuate Neuropeptide Y/Agouti-related Peptide
(NPY/AgRP), Proopiomelanocortin (POMC), and leptin receptor (LepR) expressing neurons that may contribute
to the metabolic benefits of RYGB and/or VSG. A critical question is whether the changes in arcuate neuron
activity precede or are required for the observed metabolic benefits of bariatric surgery. To address this, we will
employ electrophysiological techniques to study alterations in neuronal excitability and synaptic physiology,
providing insights into the activity patterns of these neurons before the weight loss effects are observed post-
bariatric surgery. Additionally, we will measure metabolic parameters while silencing or inhibiting the activity of
arcuate POMC, NPY/AgRP, and LepR to investigate if these neurons contribute to the RYGB and/or VSG-
induced metabolic benefits. Furthermore, we aim to explore molecular alterations in the differential responses of
POMC, NPY/AgRP, and LepR based on the type of bariatric surgery. In pursuing these research objectives, our
study seeks to understand the intricate mechanisms and cell populations involved in the metabolic benefits
induced by bariatric surgery. Together these data have the potential to inform the development of targeted
therapeutic interventions for obesity and associated metabolic disorders.

Public health relevance
PROJECT NARRATIVE The proposed research will substantially advance our understanding of the complex neural mechanisms by which bariatric surgeries like Roux-en-Y Gastric Bypass and Vertical Sleeve Gastrectomy exert their beneficial effects on obesity and metabolic disorders. By elucidating the roles of key hypothalamic neurons, this study aims to identify how these surgeries remodel brain circuits to improve metabolism. These insights could have significant clinical implications, informing the development of new therapies and other targeted treatments, thereby enhancing the management of obesity and its related metabolic disorders which are a major public health concern.